Molecular and Cellular Regulation of Pre-Leukemic Stem Cells and their Therapeutic Targeting

ABSTRACT
Clinical outcome in MDS and AML has not significantly improved over the past 50 years and cure rates remain
below 15% in the majority of patients (~85%) which are >55 years of age. Fundamentally novel approaches are
urgently needed to improve our understanding of disease pathogenesis and to enable more effective therapeutic
intervention. Evidence over the past 10 years has shown that MDS and AML arise from preleukemic stem cells
(preL-SC), preceding the formation of fully transformed leukemia stem cells (LSC). Recent work has uncovered
considerable subclonal heterogeneity of preL-SC in MDS and AML and has indicated that stem cell subclonal
complexity plays a key role in pathogenesis, progression, and therapeutic resistance. However, the molecular
and cellular mechanisms governing these processes are still largely unknown. Transcription factors (TF) have
long been recognized as critical regulators of normal and malignant hematopoiesis. Specifically, in MDS and
AML transcriptional dysregulation is key to confer the pathognomonic features of cellular dysplasia and a myeloid
differentiation block. Cell fate and differentiation decisions as well as the induction of a myeloid bias at the stem
cell and multipotent progenitor level, which is one of the earliest cellular properties detected in preL-SC, are
governed by transcription factors. In addition, our recent work has discovered an unexpected degree of
transcription dynamics and plasticity in hematopoietic stem and progenitors, and that both transcriptional
plasticity and transcriptional memory are dysregulated in preL-SC and LSC. Our major research questions/goals
are to understand stem cell subclonal dynamics and their regulation in the initiation and progression of MDS and
AML, to identify and study mechanisms of transcriptional cooperativity in pre-leukemic stem cells and their
therapeutic targeting, and to study transcription dynamics and pre-LSC fate dysregulation at a single-cell and
single-molecule resolution. To accomplish these goals we will utilize novel tools for stem cell subclonal analysis
in patients, as well as newly developed longitudinal mouse genetic models of preL-SC progression to MDS and
AML. In addition, we will leverage recent advances in our ability to directly target key transcription factors by
novel first-in-class pharmacological inhibitors, as well as novel experimental tools for the study of transcription
dynamics at a single-molecule level in primary stem/progenitor cells from murine models and patients. Overall,
our research will delineate the molecular regulation of pre-cancerous cell states in MDS and AML pathogenesis.
This will enable their therapeutic targeting, in addition to the elimination of the fully-transformed leukemic clones.
Such an approach holds the promise of achieving lasting remissions and potentially cure of MDS and AML. Our
long-term vision is that, once we understand the early transformation-initiating mechanisms in pre-cancerous
stem cells, it may even be possible to target such pre-cancerous states before the onset of overt leukemia and
thus prevent transformation.

Public health relevance
PROJECT NARRATIVE Myelodysplastic Syndromes (MDS) and Acute Myeloid Leukemia (AML) are paradigmatic cancers of the blood system that have dismal clinical outcome and cure rates have not improved in 50 years for the majority of patients. Research has shown the existence and critical role of pre-leukemic stem cells (preL-SC) and their subclonal complexity in MDS and AML pathogenesis, progression, and therapeutic resistance. The proposed research will study preL-SC subclonal complexity in patient samples and murine models, identify mechanisms of transcriptional dysregulation governing preL-SC, and test novel pharmacological approaches directly targeting preL-SC-relevant mechanisms in MDS, AML, and related pre-malignant conditions.